Administrative Core

Abstract (Administrative Core)
The goal of the Administrative Core is to coordinate the scientific, operational, and financial operations of the
entire U54 Center of Excellence. Dr. Mohammad Athar will lead the Administrative Core and will be assisted by
the leaders of the individual projects and by the core directors. The Internal and External Advisory Committees
will offer additional advice to the Administrative Core on the scientific direction of each of the projects and the
scientific cores. The Administrative Core will provide the necessary leadership, oversight, direction, and
administrative support services necessary for the timely and ethical conduction of research related to this U54
Center of Excellence. In addition, the Administrative Core will reduce the time Project and Core leaders and
other personnel need to spend on administrative details, and allow them to concentrate on the scientific goals of
the center. The Core also will facilitate interaction and communication between components of the U54 Center
of Excellence. The Administrative Core will accomplish this with the following responsibilities: 1. To plan,
coordinate and implement the administrative activities of the Projects and Cores, and to maintain sound fiscal
management of the Projects and Cores. 2. To provide oversight to the core facilities by assuring high quality and
adequate utilization of the services provided, and to evaluate resource allocation to all projects and cores. 3. To
promote productive interactions between the Projects and Cores and to foster communication that will enhance
the exchange of ideas between Project and Core scientists. 4. To coordinate evaluation by the Internal and
External Advisory Committees. 5. To interface with officials at UAB, the National Institute of Health CounterACT
Program and other regulatory agencies to ensure that there is Institutional and NIH Compliance. To coordinate
regular meetings project and core leaders. The Administrative Core will provide regular reports to the NIH
CounterACT Program on the progress of this U54 Center of Excellence. 6. To coordinate biostatistical and
bioinformatics activities to ensure that investigators have ready access to statistical/bioinformatics consultation
and support. Additional important duties of the Administrative Core will be to provide strict fiscal oversight and
to help with conflict resolution and if any should occur to resolve them in a timely manner. Finally, to also have
oversight on quality control.